MECHANISMS OF CONTRACTILE NETWORK ASSEMBLY

Project Summary/Abstract
A fundamental question in cell physiology is how appropriate levels of cell contractility are
generated to drive cell and tissue morphogenesis and mechanical homeostasis. We know cells
contractile events to enable dynamic movements. We do not know how they generate and tune
contractility in the right place at the right time. Myosin 2 filaments are the dominant force-
generating motor proteins in all cells and tissues. This proposal uses an array of molecular,
cellular, and imaging techniques to understand myosin 2 modulation and function in living
mammalian cells. We anticipate the completion of this work will answer critical questions and yield
important new avenues to pursue.

Public health relevance
Project Narrative Contractility functions from molecular to organismal scale. It participates in a wealth of processes throughout cell and developmental biology. Myosin motor proteins are the primary force producing machines that drive contractile events. Our goal is to understand how myosin 2 motor proteins function and are modulated in living cells using advanced microscopy techniques. Insights gained from this proposal have far reaching implications throughout cell physiology.